BLRD Research Career Scientist Award Application

PROJECT SUMMARY
Jie Fan, M.D., M.Sc. has been working in the VA Pittsburgh Healthcare System (VAPHS) since
2003 and is a VA Research Career Scientist, a Director of the Surgical Research Program, a Vice-
Chair of the Institutional Animal Care and Use Committee, a Mentor of VA Career Development
Awardees at VAPHS, and a tenured Full Professor of Surgery and Immunology in the Departments of
Surgery and Immunology at the University of Pittsburgh. He is a Principal Investigator working on the
cellular and molecular mechanisms of post-trauma and post-sepsis systemic inflammatory response
syndrome (SIRS) and acute lung injury (ALI), an important but exceptionally difficult area. His
laboratory has been continuously funded by VA merit review grants since 2007 and NIH research
grants (R01, P50, and R56) since 2005.
The burden of trauma- and sepsis-related diseases is considerable in veterans. Following
exsanguination and/or brain injury that commonly result in early phase death, more than 60% of
surviving patients later die of causes related to the development of SIRS, sepsis, and ALI. This patient
population is well suited for prophylactic interventions aimed at preventing these occurrences because
of the time lag before the onset of organ inflammation and failure. Nonetheless, few specific targets
have been identified that predispose to SIRS and ALI. The long-term goal of Dr. Fan's studies is to
provide a new understanding of the mechanisms of post-trauma/post-infection inflammation and organ
dysfunction and to develop novel preventive and therapeutic interventions in SIRS, sepsis, and ALI.
The studies by Dr. Fan's team will also provide a greater understanding of the pathogenesis of multiple
human diseases in which inflammation plays a central role.
ALI is one of the common endpoints of SIRS and sepsis. SIRS and sepsis are common causes of
mortality following surgery, infection, spinal injury, stroke, hemorrhage, and trauma in the veteran
population. And thus, Dr. Fan's research is highly relevant to veterans' health.
Dr. Fan is a highly productive Principal Investigator with a long track record of both VA and NIH
funding. He has also served in roles such as Co-Investigator, Consultant, and Collaborator on
numerous other's research grants. His research and collaborations have resulted in 136 peer-reviewed
publications, many of them in the first-line scientific journals, including Nature Medicine, Nature
Communications, Journal of Clinical Investigation, Hepatology, Journal of Hepatology, Cell Death &
Differentiation, and Journal of Immunology. Dr. Fan's work is renowned by his peers nationally and
internationally. He has been an invited speaker at numerous national and international conferences and
at many research and educational institutions. He serves as a regular or Ad Hoc member in a number
of national peer-review committees, including NIH, VA, DoD, American Institution of Biological Sciences
study sections, and European scientific institutions. He also serves as an editor-in-chief, member of
editorial board, and invited reviewer for over 50 scientific journals.
He has mentored 33 VA and VA WOC trainees including VA Career Development Awardee,
surgery residents, Ph.D. candidates, postdoctoral fellows, and visiting scholars, many of whom have
now become independent scientists or physician-scientists.

Public health relevance
Jie Fan, M.D., has been working at the VA Pittsburgh Healthcare System (VAPHS) since 2003 and is a VA Research Career Scientist, a Director of the Surgical Research Program, a Vice-Chair of the Institutional Animal Care and Use Committee, a Mentor of VA Career Development Awardees, and a tenured Full Professor of Surgery and Immunology in the Departments of Surgery and Immunology at the University of Pittsburgh. Dr. Fan is a Principal Investigator who has been continuously funded by VA merit review grants since 2007 and NIH research grants (R01, P50, and R56) since 2005. Dr. Fan's research seeks to answer how trauma and sepsis patients develop severe systemic inflammatory response syndrome (SIRS) and acute lung injury (ALI), the common causes of death in veterans. Dr. Fan's research is geared toward providing a new understanding of the mechanisms underlying SIRS and ALI and developing novel treatments for SIRS and ALI.